Treating Stimulant Addiction with Repetitive Transcranial Magnetic Stimulation

Stimulant use disorder accounts for significant disability and dysfunction among Veterans. We
currently do not have effective somatic treatments for this condition. This proposal will conduct a
feasibility study to determine our ability to administer and complete a double-blind, sham-controlled
randomized study using repetitive transcranial stimulation (rTMS) for treating stimulant use
disorder. Half of the participants will be randomly assigned to receive sham treatment and the other
half to receive active rTMS to the dorsolateral prefrontal cortex (DLPFC). We will also obtain pilot
data supporting the efficacy of rTMS on reducing relapse rates and improving psychosocial
functioning. And lastly, we will complete an exploratory aim in which we will obtain pilot data on the
ability of fMRI scans to yield biomarkers that will be useful in selecting which Veterans would most
benefit from intensive interventions such as rTMS

Public health relevance
Stimulant use disorder is a severe condition, responislble for a tremendous amount of disability and dysfunction among Veterans. There is currently no effective somatic treatments for this condition. New treatments for stimulant use disorder would, therefore, have signifcant impact on the health and overall well being of Veterans. We propose demonstrating the feasibility of conducting a study of repetitive transcranial magetic stimulation (rTMS), a non-invasive, safe method for delivering electrical current for the treatment of stimulant use disorder.